Biophysical and genetic mechanisms underlying diaphragm morphogenesis and Congenital Diaphragmatic Hernias

Project Summary
The diaphragm is a critical skeletal muscle that separates the thoracic from the abdominal cavity and drives
the inspiration phase respiration. Defects in diaphragm development cause congenital diaphragmatic hernias
(CDH), a common structural birth defect (1 in 3,000 births) where abdominal contents herniate into the thorax,
obstructing lung development and leading to 50% neonatal mortality. Despite the functional significance of the
diaphragm and the prevalence of CDH, the biophysical properties underlying hernia formation and the
contribution of extracellular matrix (ECM) to the structural integrity of the diaphragm is largely unexplored. This
proposal will test the hypothesis that defects in ECM organization lead to alterations in connective tissue
stiffness associated with hernias (Aim 1), determine whether connective tissue fibroblasts are a critical source
of ECM (Aim 2), and identify ECM components regulated by the transcription factor GATA4, a gene strongly
associated with CDH (Aim 3). My recent work has demonstrated how mutations in key regulators of muscle
progenitor migration lead to a diaphragm with partial muscle, where regions of connective tissue lack muscle
but critically do not herniate. By directly comparing herniated connective tissue (using a previously established
model of CDH) to amuscular regions that maintain their structural integrity, I will investigate biomechanical
properties as well as ECM composition and organization associated with tensile strength in the diaphragm.
This research will identify the embryonic source of key ECM components (K99), clarify how collagen and
elastin crosslinking impacts tissue mechanics in the diaphragm (K99, R00) and characterize therapeutic
candidates affecting stiffness of diaphragm connective tissue fibroblasts (R00). The proposed experiments will
provide me with valuable training in mouse genetics, atomic force microscopy, and mass spectrometry. Under
the mentorship of Dr. Gabrielle Kardon, I will gain the experience and training necessary to transition to an
independent academic position. To further my career development, I will present my research at conferences,
mentor students, attend relevant courses, and publish my findings. My assembled K99 mentorship committee,
composed of Drs. Jeff Weiss, Vladimir Hlady, Kirk Hansen, Benoit Bruneau and Kristen Kwan, will provide the
necessary expertise to perform biophysical measurements in cells and ex vivo tissues, incorporate these
measurements into finite element models of the diaphragm, characterize the ECM profile of diaphragm
connective tissue with quantitative precision, and analyze the GATA4 transcriptional network in the developing
diaphragm. The Pathway to Independence Award will enable me to pursue an ambitious research program
investigating ECM regulation of connective tissue structural integrity in musculoskeletal development.

Public health relevance
Project Narrative Congenital Diaphragmatic Hernia (CDH) is a common birth defect (1 in 3000 births) where abdominal contents herniate into the thoracic cavity through a weakness in the developing diaphragm, an essential skeletal muscle. This research will use mouse as a model system to study the biophysical properties associated with hernias and delineate extracellular matrix structure, organization, and transcriptional regulation in normal and defective tissue. This will provide new directions for understanding the mechanistic basis of herniation.